Johns Hopkins-Tufts Trial Innovation Center

This study is part of the NIH’s Helping to End Addiction Long-term (HEAL) initiative to speed scientific solutions to understand the basis of pain and enhance clinical pain management.

Public health relevance
NARRATIVE The NIH has created the Helping to End Addiction Long-term (HEAL) initiative to speed scientific solutions to the national opioid public health crisis. Trials will be conducted through the NIH HEAL Pain Management Effectiveness Research Network (HEAL Pain ERN), which will use the infrastructure of the NCATS Trial Innovation Network to provide scientific guidance and coordination of the HEAL Pain ERN Trials. Three Trial Innovation Centers (TICs) will provide integrated functions for the clinical coordinating center, data coordinating center, and Biostatistics Core. The Johns Hopkins/Tufts TIC will serve as the Biostatistics Core.